FACILITIES SERVICES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Facilities Services is responsible for maintenance, building construction and renovations, HVAC systems and controls, groundskeeping, waste disposal, sewerage treatment plant operation, and day-to-day operations in the power plant and boiler room. The unit is also responsible for compliance with relevant local, state and federal regulations that govern the Center's facilities operations. Facilities Services maintains ten main buildings (approximately 140,000 ft^2) and 69 primate field cages located on the Center's 500 acres. In addition to the ten main buildings, the Center has numerous other buildings such as generator sheds and storage buildings that support the Center's operations.